Pediatrics & Pulmonary Network: Improving Health Together

PROJECT SUMMARY
Despite improvements in air quality, decreases in smoking rates, and innovations in healthcare, respiratory
health remains a problem in the United States with a high prevalence of respiratory disorders and many
individuals with suboptimal lung function. Sleep disorders in children are also increasing, affecting both social-
behavioral development and long-term morbidity. Disproportionate declines in health have occurred in
populations with socioeconomic disparities and in underrepresented minorities. Identifying and decreasing health
disparities remain a challenge in both research and clinical care. In order to identify lung and sleep disorders
early and address these urgent issues in pulmonary health and health inequity, we must build collaborations
between subspecialists, general pediatricians, schools, communities, and families. To foster these collaborations
and improve care, we propose an in-person meeting focused on building a research and clinical care agenda in
respiratory health in children. We have previously identified key opportunities to improve pulmonary and sleep
health including A) Developing longitudinal childhood cohorts to evaluate factors that affect pulmonary and sleep
health, B) Improving diagnostic measures by implementing existing biomarkers and developing and testing novel
biomarkers of pulmonary and sleep health, C) Improving the implementation of pulmonary and sleep-focused
patient reported outcomes, electronic health records and large data sets, and mobile/wearable technologies
within general pediatric practices, and D) Improving pulmonary function testing within young children. The
objectives of this conference are to summarize critical knowledge gaps and key steps to improve respiratory
health in the population, create a partnership between pediatrics and pulmonologists as the Pediatric &
Pulmonary Network, address social inequities affecting respiratory health in both clinical care and research, and
promote the future of the workforce including junior investigators interested in respiratory health. Anticipated
products of the meeting are competitive interdisciplinary grant applications, new guideline development, and
conference manuscripts detailing identified priorities. This meeting is relevant to the mission of the NIH as it aims
to develop a research and clinical care agenda that will have impacts to health across the lifespan by improving
respiratory health in childhood.

Public health relevance
PROJECT NARRATIVE The purpose of this conference is to improve lung and sleep health in children through a collaborative effort between pediatric pulmonary and sleep experts and general pediatricians. The meeting is the first step to create a research and clinical care agenda that will lead to significant improvements in respiratory health. The meeting is relevant to the mission of the NHLBI as it will address key gaps in care, address inequities that affect child health, and emphasize training and mentoring of young investigators.